Surviving an Epidemic: Families and Well-Being, Malawi 1998-2020

Surviving the Epidemic: Families and Well-Being, Malawi 1998–2020
Project Summary: Across Eastern and Southern Africa (ESA), a remarkable cohort is reaching middle and older
ages: those who have survived the AIDS epidemic. Some were infected with HIV, but everybody in this co-
hort was affected by HIV. Nobody could escape an epidemic that was devastating for both its health and social
implications, and one that struck hard in a region also dealing with poverty, famines, and basic uncertainties
of life. Were the survivors of this cohort just lucky? What promoted survival and resilience in such a terrible
context, and what inﬂuenced health and well-being among the survivors and their families? How is present
demographic change, health, well-being and economic development in ESA shaped by the experience of the epi-
demic and by the strategies used to survive the epidemic? These and related questions about “Surviving the
Epidemic” (STE) will be studied by exploiting an unusually rich data source: the Malawi Longitudinal Study
of Families and Health (MLSFH) cohort, 1998–2020. The motivation to expand, publicly-release and analyze
the MLSFH until 2020 is multifold: (a) The MLSFH 1998–2020 will provide a unique opportunity to investigate
questions about STE, an opportunity not available from other ESA data. (b) The MLSFH 1998–2020 will also
be exceptional in allowing researchers to understand how the epidemic and the strategies for STE employed by
individuals and families continue to shape the epidemiological and demographic transitions in ESA. (c) The end
of the epidemic will almost certainly not mark the end of global health crises (an example at the time of this
submission is the considerable concern about Zika in the Americas), and we need to better understand the mech-
anisms of how low-income country citizens cope with such crises. The Speciﬁc Aims for the MLSFH 1998-2020
therefore include: Aim 1: Collect and publicly-release new MLSFH data from 2016–20 for (a) surviving MLSFH
respondents and their families, (b) children of surviving and deceased respondents, and (c) migrants, with an
expected N(surveyed) 6,300 plus data on 1,200 deceased respondents. The topics to be covered include well-
being, mortality & morbidity, family & household dynamics, social capital & networks, physical & mental health,
household production & consumption, and intergenerational relations. Aim 2: Using the MLSFH 1998–2020 and
diverse methodological approaches for longitudinal data ranging from ethnographic methods to econometric
structural equation modeling, analyze the determinants of STE by identifying the factors, social contexts and
individual/household behaviors inﬂuencing survival, resilience, and well-being among MLSFH respondents,
their children, and other family members. Aim 3: Analyze the consequences and lasting imprints of STE on
(a) physical/mental health and non-communicable diseases among surviving adults and children of survivors
and non-survivors, (b) fertility, investments in children and human capital in families differentially affected by
the epidemic and STE, (c) migration and remittances, and (d) coping capabilities for new shocks and crises.

Public health relevance
Narrative/Public Health Relevance: Future global health crises are certain, and a better understanding of how low- income country citizens cope with such crises, how policies and programs can enhance these strategies, and how past crises affect current behaviors and health outcomes is essential for improving health in poor countries with weak health systems. To investigate these issues, the cohort of the Malawi Longitudinal Study of Families and Health (MLSFH) from 1998–2020 will be studied to learn: what predicted survival, and which factors inﬂuenced resilience, well-being and current health and demographic behaviors among the cohort of individuals (and their families) who survived the AIDS epidemic and are now reaching middle to old age in Eastern and Southern Africa?